Administrative Core

Summary – Administrative Core
This NIDA supported Center of Excellence aims to stimulate the University of Arizona’s research on the
neurobiology of addiction and relapse. The Center of Excellence in Addiction Studies (CEAS) consists of
three Research Cores (Genetic Targeting, Neuroanalytical, and Behavioral), a Pilot Research Project (PRP),
and the Administrative Core (AC). The AC functions as the focal point for coordination and implementation of
the activities of the Cores and PRP, providing financial and regulatory oversight, a data repository, and
community information sharing. The main goals of the AC are to operate the CEAS seamlessly promoting
maximal synergy and impact between the Cores and PRP for the research of the users that will lead to new
proposals for addiction research. The AC oversees all activities of the Center and coordinates the
interdisciplinary, multi-PI and multi-core interactions along with providing administrative support. The
functions of the AC fall into four main categories: (1) coordinate meetings, invited lectures, consulting, retreat,
internship program, travels; (2) coordinate requests from users for experiments; (3) establish a database for
experimental data and data sharing; and (4) prepare yearly progress reports, and provide financial and
regulatory oversight. The AC provides a formal and centralized mechanism to accomplish these functions
that will ensure that the activities of the Cores and PRP are carried out efficiently, as well as insuring that the
benefits of the information that result from these activities are shared within the Center and with the scientific
community in compliance with local and federal regulations. The coordination of all of these activities is what
the AC will do to enable success.